Development of FAPI PET as a Non-invasive Biomarker of Liver Fibrogenesis

PROJECT SUMMARY/ABSTRACT
The overall goal of this revised proposal is to address the important unmet need for noninvasive detection
and assessment of liver fibrogenesis, the pathologic process resulting in liver scarring and fibrosis. Fibrosis
is the cumulative end-result of all chronic liver diseases (CLD) that affect ~1.5 billion people globally. This study
will be enabled by using positron emission tomography (PET) through specific in-vivo targeting of the activated
(fibrogenic) hepatic stellate cells (HSCs), the cornerstone of liver fibrogenesis and fibrosis.
While non-invasive techniques for assessment of fibrosis have been developed and validated (e.g., magnetic
resonance elastography, MRE), there is lack of a much-needed non-invasive biomarker to measure fibrogenesis,
which is especially significant in the setting of drug-discovery. Development trials and eventual clinical im-
plementation of antifibrotic drugs require non-invasive detection and quantification of active fibrogenesis. As a
current limitation, assessment of treatment response through measuring fibrosis requires several months due to
the time lag between reduction in fibrogenesis and subsequent decrease in fibrosis. Moreover, even if a drug is
effective, MRE may not detect a change in liver stiffness despite improvement in histologic, serologic, and/or
other imaging markers. Hence, non-invasive assessment of liver fibrogenesis is urgently needed.
We have demonstrated successful non-invasive preclinical assessment of liver fibrogenesis through a
fundamentally innovative strategy using PET. Fibroblast activation protein (FAP) is specifically expressed by
activated HSCs. We have demonstrated that in our human-sized model of alcohol-induced liver injury, uptake
of radiolabeled FAP inhibitor (FAPI) on PET directly correlates with fibrogenesis and fibrosis. Moreover, mouse
studies have demonstrated reduced FAP expression with fibrosis reversal. However, there is need for sys-
tematic evaluation of the relationship between FAPI PET and tissue markers of fibrogenesis (1) across all
grades of liver injury, and (2) in both presence and absence of the hepatotoxin. This requires further preclinical
evaluation of FAPI PET in a controlled setting and subsequent translational evaluation in patients. We aim
to (1) Determine the relationship between liver FAPI uptake and tissue markers of fibrogenesis across all stages
of liver injury in our swine model of liver injury; (2) demonstrate that decreasing liver FAPI uptake is a biomarker
for decrease in fibrogenesis and its tissue markers, preceding any reversal in fibrosis; (3) determine the rela-
tionship between liver FAPI uptake and tissue markers of fibrogenesis in a pilot clinical study in CLD patients.
Successful completion of these aims by our unique and highly qualified multidisciplinary team will lay
the foundation for future clinical trials for definitive validation in patients and to fulfill the unmet need of a non-
invasive biomarker for liver fibrogenesis. The development of this biomarker will have a meaningful impact on
the care of ~1.5 billion people with CLD through (1) facilitating the development of antifibrotic pharmacothera-
peutics (2) early detection of fibrogenic liver disease, and (3) monitoring of fibrogenesis in response to treatment.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE STATEMENT The broad, long-term objective of our research is to improve the health of the ~1.5 billion people in the world with chronic liver disease that can progress to liver failure, liver cancer, and liver-related death. We seek to develop and validate non-invasive methods of assessing the activity of chronic liver disease. These methods will reduce the need for biopsy, permit earlier diagnosis, and facilitate more effective treatment, thereby pre- venting the serious long-term complications of chronic liver disease.